TREATMENT OF HEPATITIS C WITH AMANTADINE: DOSE ESCALATION STUDY

Hepatitis C may in time result in progression damage to the liver and lead to cirrhosis or liver cancer. Interferon alone or in combination with Ribavarin are the only FDA-approved therapies for Hepatits C infection. Treatment in the early stages may prevent progression to cirrhosis. Interferon has several undesireable side effects, therefore, investigators are looking for new drugs that may be useful in the treatment of Hepatitis C. Amantadine is a drug that was developed 35 years ago for the treatment of the flu. Previous research has shown that amantadine may be useful for patients with Hepatitis C and results in a 30% response rate when given at a dosage of 200mg daily. The purpose of this study is to evaluate the efficacy of amantadine in hepatitis C with higher doses of the drug.